PROTOCOL INFORMATION OFFICE (PIO) SUPPORT SERVICES FOR THE PROCESSING OF CLINICAL TRIAL PROTOCOL DOCUMENTS AND TRACKING THE IMPLEMENTATION AND COMPLETION OF HUMAN CLINICAL RESEARCH STUDIES. PERFORMANC

The major objective of this requirement is to provide support, which is defined by the five project areas detailed below, to the NCI, DCP Protocol Information Office (PIO).

The five project areas are:
Project Area 1. Abstraction of Key Elements from Protocol Related Documents
Project Area 2. File Management
Project Area 3. Clinical Trial Review Support
Project Area 4. Manage People (persons such as investigators, coordinators, reviewers. etc.) and Organization’s data in DCP Clinical Trials Database
Project Area 5. PIO Operational Support